Writing to Heal: A Culturally Based Brief Expressive Writing Intervention for Chinese Immigrant Breast Cancer Survivors

Project Summary/Abstract
The unavailability of culturally competent mental health care for Chinese immigrant breast cancer survivors
and their unmet psychological needs characterize the health disparity experienced by Chinese immigrant
breast cancer survivors. Breast cancer is the cancer with the highest incidence rate among the Chinese
population and Chinese immigrant breast cancer survivors have lower quality of life compared to their non-
Hispanic white counterpart. However, interventions to improve quality of life are lacking among this
immigrant population. Expressive writing intervention uses writing prompts to promote health by facilitating
emotional and cognitive processes. Guided by Western and Eastern theories and preliminary studies
showing the benefits of expressive writing among Chinese immigrants, this study proposes to test the health
effects of an innovative and brief writing intervention among Chinese immigrant breast cancer survivors
using a randomized controlled trial and mixed methods design. Chinese immigrant breast cancer survivors
(N=240) will be randomly assigned either to a control condition to write about neutral topics or to one of two
intervention conditions, self-regulation and self-cultivation, which both aim to promote adaptive cognitive
processes but differ in how they achieve this goal. The self-regulation intervention incorporates a traditional
Western expressive writing paradigm, whereas the self-cultivation intervention incorporates Asian cultural
values. Participants in all three conditions will be asked to write in Chinese during three weekly 30-minute
sessions. The primary outcome will be QOL, and the secondary outcomes will be perceived stress, stress
biomarkers, and medical appointments for cancer-related morbidities. Self-reported health outcomes (QOL
and perceived stress) will be assessed at baseline and 6- and 12-month follow-ups. Stress biomarkers
(salivary cortisol and alpha-amylase) will be assessed at baseline and 6-week follow-up, and perceived
stress will also be self-reported at the 6-week follow-up. Medical appointments up to the 12-month follow-up
will be self-recorded and verified by medical record. We hypothesize that the two intervention conditions will
improve quality of life, reduce perceived stress and medical appointments for cancer-related morbidities, and
normalize stress biomarkers. Few studies have tested evidence-based programs in communities of color,
and even fewer have tested culturally based interventions that adopted the cultural values of the
underserved communities. We expect that the proposed study, guided by theory, practices, and methods
and tailored for an underserved population, will inspire new directions in research to address these
scientific and practical needs in health disparities research.

Public health relevance
Project Narrative/Public Health Relevance Statement Psychosocial interventions have been shown to be effective for the mainstream population of breast cancer survivors, but few psychosocial interventions have been successfully designed for ethnic groups of color. This proposed study is a randomized controlled trial to assess the impact of a culturally based brief writing intervention among Chinese immigrant breast cancer survivors, an underserved and understudied population. The study will help to reduce or eliminate the unnecessary emotional and physical health disparities in cancer care among Asian American breast cancer survivors and potentially other ethnic groups of color as well.